Immune System Development and Regulation

This program requests the continuation of 4 predoctoral positions for training in immune system development
and regulation (ISDR). The program includes 26 faculty trainers with expertise in the development and regulation
of the immune system, who are a subset of the Immunology Graduate Group (IGG) at the University of
Pennsylvania. This discipline-based training program has a >40-year record of outstanding training. The
academic elements of the IGG curriculum form the core experiences for trainees in the ISDR program, and
reflect a proven yet evolving mixture of coursework, laboratory rotations, research presentations, and thesis
research. These are enriched by a large array of additional activities that foster scientific exchange and
discussion, including our annual 2.5-day retreat, weekly guest seminar program, weekly research-in-progress
series. Moreover, there are several ISDR-specific enrichment activities for data sharing and professional
development, as well as an agreement that affords training with adjunct faculty on the NIH Bethesda campus.
The assembled trainers for this grant have highly productive training records in the area of immune system
development and regulation, as well as over $39M in annual research support to assure quality and continuity
of the training experience. The breadth and strength of the assembled training faculty affords a diverse array of
potential trainee mentors. The program has over 200 applicants annually, which are a subset of over 1,000
applicants to biomedical graduate studies at the University of Pennsylvania. The IGG program recruits between
8 to 14 PhD and 2 to 5 MD-PhD trainees per year, yielding a student body of ~60 students, and the ISDR supports
a subset of the upper 15% of these. The ISDR focuses specifically on students/faculty whose research is directed
towards understanding the development and regulation of the immune system and immune responses. In this
regard, the ISDR fosters research training that bears directly on control and manipulation of the immune system
in health and disease.

Public health relevance
The immune system governs responses to pathogens and vaccines, and deregulation of immune responses can lead to inflammatory and autoimmune diseases. This program will prepare outstanding scientists to study immune system development and regulation. This will ultimately foster advances in vaccine development and organ transplantation, as well as therapies and immunotherapies for autoimmune disease and cancer.